Aging and task-specific training to reduce falls

The proposed study employs a randomized, controlled design to assess the immediate and long-term effects of
task-specific balance training for reducing environmental falls in at-risk community-dwelling older adults. >33%
of older adults fall at least once each year, leading to serious injuries (e.g., hip fractures, head injuries) and
comorbidities (e.g., Alzheimer’s disease and related Dementias). Most falls occur due to environmental
disturbances which cause a loss of balance while walking (i.e., slips, trips). Overground perturbation training
(repeated exposure to unpredicted perturbations) improves both volitional/anticipatory and reactive balance
control and reduces real-life falls among older adults. However, overground perturbation training is not suitable
for routine clinical application due to its complex design, space, and technology requirements. An alternative
method for delivering perturbation training is commercial treadmill systems, which not only can enhance fall-
resisting skills but are more feasible for community-translation. However, the equipment is costly and the
translational effectiveness of treadmill perturbation training for reducing falls in community ambulatory older
adults is lesser than overground training, probably as it mainly only entrains reactive balance control. Falls
may also occur due to deficits in volitional balance control which affect gait stability during daily living. Training
paradigms focused on improving volitional balance control have primarily comprised of conventional balance
exercises delivered as a part of physical rehabilitation; however, conventional balance exercises generally do
not translate to improvements in reactive balance control when exposed to an unpredicted external perturbation
and have limited effects on reducing real-life falls. A fall prevention intervention that targets both volitional
and reactive balance domains could more effectively reduce falls than existing paradigms which only train a
single domain (e.g., treadmill perturbation training: reactive-dominant, or conventional balance: volitional-
dominant). We have developed a novel task-specific balance program that includes both functional tasks and
predictable perturbations specific to slips and trips and requires little set-up and equipment, making it a cost-
effective, feasible and accessible fall prevention intervention. We will compare the effects of 8 weeks (16
sessions) of task-specific balance training with established fall prevention paradigms including treadmill
perturbation training and conventional balance training. We will examine the immediate effects of task-specific
balance training on reactive balance (Aim 1) and volitional balance (Aim 2). Additionally, we will evaluate the
longer-term retention (18 months) of task-specific balance training and effects on real-life falls and falls efficacy
(Aim 3). In an exploratory aim, will also examine the neuromuscular adaptations induced through training using
simulation techniques (Aim 4). If successful, our novel intervention can be implemented as a feasible, safe, and
effective fall-prevention intervention and has large potential for direct dissemination to clinical settings.

Public health relevance
The United States is an aging society where 1 in 3 healthy older adults experiences a fall every year, causing serious injuries and posing an enormous burden for the healthcare system; yet current fall prevention programs such as conventional balance training fail to reduce fall incidence, potentially due to their lack of task-specificity for acquiring fall resisting skills to recover from environmental falls. Over the past two decades, our work has established that repeated exposure to slip and trips in a safe environment can prevent falls up to 1 year after such training; however, such interventions are expensive, require complex technology, and are not readily scalable to clinics and community living facilities. In this study, we will provide cost-effective, safe and easy to translate task-specific balance exercises consisting of functional tasks and predictable perturbations targeted to reduce real-life falls.